Functional dissection of the Klrg1+ regulatory T cell subset in health and diseases

In the past two decades, regulatory T (Treg) cells have emerged as a dedicated immune population crucial for
the negative regulation of immune responses. Nonetheless, the precise effector mechanisms underlying Treg
cell-mediated suppression in a specific tissue microenvironment under a particular immunological condition
remains incompletely understood. To date, accumulating evidence has suggested that similar to the
conventional T (Tconv) cells they regulate, Treg cells come in “different flavors” both phenotypically and
functionally. In addition to the heterogeneity of the Treg cells that control different types of T cell immune
responses, the presence of distinct Treg cell populations in many nonlymphoid tissues have also started to be
appreciated. In this proposal, though establishing a novel mouse model that could allow us to deplete a
desired Treg cell subset in a temporally controlled manner, we will determine the cellular role of a specific
Klrg1-expressing Treg cell population in maintaining peripheral tissue homeostasis under both physiologic
and pathologic conditions. Moreover, by employing a cutting-edge single-cell transcriptomic approach, we
will gain further molecular and cellular insights into the impact of Klrg1+ Treg cell depletion on the immune
system in a particular tissue microenvironment in an unbiased manner. Collectively, our proposed studies will
not only provide a comprehensive assessment of the Klrg1+ Treg cell subset in Treg cell-mediated immune
regulation but will also facilitate a better understanding of the potential effector mechanisms by which Klrg1+
Treg cells maintain peripheral tissue homeostasis. Accomplishing the aims proposed in this application will
undoubtedly extend our fundamental knowledge of a distinct Treg cell subset in immune regulation and
provide further insights into the development of new therapeutic means targeting Treg cells to treat a wide
range of human immune disorders.

Public health relevance
Through establishing a novel animal model that affords the opportunity to specifically eliminate a desired Treg cell subset combined with the employment of a single-cell, sequencing-based method, the proposed research aims to comprehensively examine the role of a specific Treg cell subset in establishing peripheral immunological tolerance and maintaining tissue homeostasis. Accomplishing the aims proposed in this application will greatly extend our fundamental knowledge of Treg cell-mediated immune regulation, particularly in non-lymphoid tissues and provide further insights into the development of new therapeutic means to treat human immune disorders.